Validation of a microRNA panel to pre-symptomatically predict the risk of radiation-induced fibrosis

Abstract
ChromoLogic has identified a small panel of four circulating microRNA (miRNA) sequences that can be used to
predict the onset of radiation-induced lung injury from plasma samples taken approximately 15–30 days post-
exposure. These miRNAs are linked to genes associated with profibrotic signaling pathways (e.g., TGF-β and
BMP signaling) that are differentially regulated in fibrotic lung tissue following radiation exposure. A Bayesian
predictive model (the miDOS assay) was developed using this panel through the analysis of mouse (N = 128),
non-human primate (N = 67), and human (N = 303) miRNA responses to irradiation and longitudinal
assessment of pneumonitis and fibrosis. An initial assessment of the miDOS assay in human patients (N = 21)
was performed at the Greater Los Angeles Veteran's Administration Medical Center (VA) in lung and breast
cancer patients that received radiotherapy (RT) suggested the miDOS assay had good performance in this
patient population (area under the ROC curve = 0.85). Based on feedback from the FDA following a pre-
submission meeting (April 2022 Q230171) discussing the miDOS assay, ChromoLogic and Dr. Diana Gage,
M.D. (VA/UCLA) propose to advance the development of this miRNA-based predictive assay for radiation-
induced lung injury by (i) validating the performance of the assay in a larger patient population (N = 100); (ii)
assessing the impact of cancer on baseline miRNA levels; (iii) assessing the longitudinal dynamics of miRNA
abundance following radiation treatment; (iv) evaluating the impact of potential confounders on panel miRNA;
and (v) evaluating the impact of an expanded miRNA panel on the specificity and sensitivity of the assay.

Public health relevance
Project Narrative Lung injury is a late sequela of acute exposure to ionizing radiation and clinical radiotherapy (RT). Pneumonitis and fibrosis can result in morbidity or mortality months after exposure. Currently, there are no established methods to identify individuals at risk of late lung injury following radiation exposure. To address this urgent unmet need, ChromoLogic has developed an assay, based on a small panel of circulating microRNA (miRNA) linked to genes associated with profibrotic signaling pathways that are differentially regulated in fibrotic lung tissue following radiation exposure, that predicted the onset of radiation-induced lung injury in a pilot study. Here, we will test the performance of the assay in a larger patient population (N = 100).